Reconstructing and deconstructing intracellular signaling at the membrane-cytosol interface

PROJECT SUMMARY (See instructions):
In receptor signal transduction, a major goal is to understand how a complex network of biochemical
interactions at the cell membrane is spatially coordinated to generate specific cellular responses. It is
generally thought that this level of complexity is essential for the tight regulation of information processing
in cells, as defects in signaling have been linked to numerous diseases. However, the complexity has
created a gap between reconstituted systems and living cells, limiting progress toward a mechanistic
understanding of signal transduction. This proposal addresses this challenge by developing a total
reconstitution approach that substantially advances our ability to reconstruct complex signaling networks,
approaching those in cells, while retaining the experimental strengths of an in vitro approach. We propose
a hybrid approach, introducing undiluted cell extracts into model membrane systems, to overcome the
fundamental limitations of traditional reconstitution methods and reconstitute cellular complexity. This
innovation enables the reconstitution of intracellular signaling as an integrated entity rather than isolated
compartments, thus clarifying how signals are amplified, sustained, or attenuated at the membrane. The
R00 phase has two aims: 1) reconstituting the receptor tyrosine kinase (RTK) pathway and 2) dissecting
the spatiotemporal mechanisms in the RTK pathway. Specific emphasis is placed on using the
reconstituted system to study the pressing question of how RTK condensates regulate Ras GTPase
activation. The findings are expected to contribute to a quantitative model of RTK signaling, establishing a
paradigm for studying other signaling pathways. Such efforts are bringing us beyond a descriptive
understanding of signal transduction to a mechanistic framework, offering quantitative insights into
abnormal signaling in disease and alternative strategies for therapeutics.

Public health relevance
RELEVANCE (See instructions): Signal transduction by cell-surface receptors is a primary way mammalian cells process chemical information. When this process breaks down, disease, most notably cancer, often occurs. This project aims to develop a new reconstitution approach to define, manipulate, and analyze complex signaling systems at the cell membrane, thus offering insights into the molecular mechanisms of information processing in healthy cells-and disease-associated cells.